Analysis Core

ANALYSIS CORE ABSTRACT
American Indians/Alaska Natives (AI/ANs) and Native Hawaiians/Pacific Islanders (NHPIs) have a high
prevalence of risk factors for Alzheimer’s disease and related dementias (ADRD), including vascular brain injury
and other cognitive impairments. Yet we have limited data on ADRD in AI/ANs and NHPIs; even reliable
prevalence estimates are lacking. One barrier to remediating this lack of knowledge is the fact that existing
methods and measures for identifying, diagnosing, and evaluating ADRD are often inappropriate for use with
these populations, which experience unique social, cultural, and environmental influences on ADRD. Most
available studies on ADRD contain far too few members of these populations to permit meaningful analysis of
distinct population subgroups. Therefore, we will conduct studies with AI/AN and NHPI cohorts and datasets
using methods and instruments that yield accurate, reliable data on topics relevant to ADRD. The Native
Alzheimer’s Disease-related Resource Center in Minority Aging Research (RCMAR) emphasizes health
disparities and ADRD as the focus of Pilot Studies led by early- or mid-career investigators RCMAR Scientists
that will provide the experience and mentorship they need to contribute to a rapid expansion of the scope and
quality of ADRD research with AI/ANs and NHPIs. The goal of the Analysis Core is to optimize the quality of Pilot
Studies conducted by RCMAR Scientists. We draw on 20 years of experience with the Native Elder Research
Center RCMAR, which is jointly run by the University of Colorado and Washington State University. We also
benefit from collaborative relationships with investigators from Alzheimer’s Disease Centers. This Core will
ensure that Pilot Studies make efficient use of study resources, apply methods that optimize validity, and yield
findings with clear and meaningful inference to the larger population of interest. We will integrate diverse methods
from epidemiology, biostatistics, health economics, health services and policy, and health outcomes research,
and we will augment our robust quantitative capacity with exceptional experience in qualitative methods specific
to underrepresented minority communities. Thus, the Specific Aims of the Analysis Core are to: 1) Collaborate
with the Research Education Component to develop and implement methods to optimize the validity, inference,
and generalizability of Pilot Studies and future funding applications; 2) Provide structured support and formal
didactic instruction to RCMAR Scientists; and 3) Develop and critically evaluate a catalog of datasets containing
information on the health of AI/ANs and NHPIs that can used by RCMAR Scientists and future ADRD
Investigators. If ADRD is as prevalent in these groups as in Whites, we would expect more than 78,800 elderly
AI/ANs and 18,000 elderly NHPIs to be affected. The size of this at-risk population underscores the substantial
public health importance of the program we propose. Therefore, the work of the Analysis Core will maximize
scientific rigor while accommodating the logistical and methodological challenges that not infrequently arise in
real-world research with underrepresented communities.